Mining Cryptic Biosynthetic Gene Clusters for Novel Bioactive Compounds and Biocatalysts

PROJECT SUMMARY/ABSTRACT
Natural products from the soil-dwelling bacteria Streptomyces have been a rich source of medicines. Additionally,
the enzymes that produce natural products perform unique and challenging chemistry, providing inspiration for
novel biocatalysts. One important class of natural products is cyclic nonribosomal peptides. Unfortunately, the
discovery of novel cyclic peptides using traditional techniques is often unsuccessful. Also, chemical synthesis of
cyclic peptides, especially small strained tetrapeptides, remains a challenge, resulting them being underexplored
as potential therapeutics. Genomics data suggests a plethora of novel Streptomyces cyclic peptides and their
biosynthetic enzymes remain to be discovered. However, the biosynthetic machinery responsible for producing
these novel natural products is often cryptic (i.e. transcriptionally inactive). A significant gap remains in the
strategies available to discover new bioactive cyclic peptide natural products and to synthesize these peptides,
especially cyclic tetrapeptides, for further analysis. Our long-term goals are to 1) Discover biosynthetic enzymes
that perform unique and challenging reactions and develop these enzymes as biocatalysts, and 2) Develop
bioinformatics and synthetic techniques that allow us to directly access natural products from cryptic biosynthetic
gene clusters. Our current research objectives are to 1) Determine activities and substrate scopes for
previously identified, as well as bioinformatically predicted, tetrapeptide cyclases and develop the most promising
ones as biocatalysts and 2) Utilize bioinformatics methods to identify nonribosomal peptides of interest followed
by direct chemical synthesis and biological testing to identify bioactive leads. Our recent discovery of the first
standalone tetrapeptide cyclase and our development of the Synthetic Natural Product Inspired Cyclic Peptide
(SNaPP) methodology, make us well positioned to complete these objectives. The central hypothesis of the first
project is natural product biosynthetic enzymes will be efficient biocatalysts for the generation of cyclic
tetrapeptides that otherwise are very challenging to access. The objectives of the first project are to 1) better
understand the mechanism of Ulm16, a known tetrapeptide cyclase 2) bioinformatically identify new tetrapeptide
cyclases and 3) apply these tetrapeptide cyclases to the synthesis of bioactive cyclic tetrapeptides and the
development of cyclic tetrapeptide libraries for screening. In the second project, we are directly chemically
synthesizing natural products that are bioinformatically predicted from nonribosomal peptide synthetase
biosynthetic gene clusters. While our previous work in this area has resulted in promising bioactive leads,
challenges remain including accurate predictions of off-loading methods, unnatural amino acids, and tailoring
enzymes. The objectives for the second project are to address these challenges by incorporating predictions of
these three areas into our predicted peptides and then synthesizing them. This work will provide access to many
novel natural product scaffolds that are currently inaccessible and that are likely to have interesting bioactivities.

Public health relevance
PROJECT NARRATIVE The soil-dwelling bacteria Streptomyces make numerous cyclic peptides that humans use as medicines. Analysis of the DNA of these bacteria suggests they have the potential to make many more, but they do not make them under standard laboratory conditions. The objectives of this proposal are to 1) computationally predict these cyclic peptides, chemically synthesize them, and test them for interesting bioactivities and 2) to develop biocatalysts to enable access to challenging to synthesize peptides, including strained cyclic tetrapeptides.